CRCNS: US-France Data Sharing Proposal: Lowering the barrier of entry to network neuroscience

The field of network neuroscience has developed powerful analysis tools for studying brain networks and holds promise for deepening our understanding of the role played by brain networks in health, disease, development, and cognition. Despite widespread interest, barriers exist that prevent these tools from having broader impact. These include (1) unstandardized practices for sharing and documenting software, (2) long delays from when a method is first introduced to when it becomes publicly available, and (3) gaps in theoretic knowledge and understanding leading to incorrect, delays due to mistakes, and errors in reported results. These barriers ultimately slow the rate of neuroscientific discovery and stall progress in applied domains. To overcome these challenges, we will use open science methods and cloud-computing, to increase the availability of network neuroscience tools. We will use the platform brainlife.io for sharing these tools, which will be packaged into self-contained, standardized, reproducible Apps, shared with and modified by a community of users, and integrated into existing brainlife.io analysis pipelines. Apps will also be accompanied by links to primary sources, in-depth tutorials, and documentation, and worked-through examples, highlighting their correct usage and offering solutions for mitigating possible pitfalls. In standardizing and packaging network neuroscience tools as Apps, this proposed research will engage a new generation of neuroscientists, providing them powerful new and leading to new discoveries. Second, the proposed research will contribute growing suite of modeling analysis that can be modified to suit specialized purposes. Finally, the Brainlife.io platform will serve as part of the infrastructure supporting neuroscience research. Altogether, these advances will lead to new opportunities in network neuroscience research and further stimulate its growth while increasing synergies with other domains in neuroscience.

Public health relevance
Structural and functional networks support cognitive processes. Miswiring networks lead to maladaptive behavior and neuropsychicatric disorders. Network neuroscience is a young field that provides a quantitative framework for modeling brain networks. This project will make network neuroscientific tools available to new users via open science and cloud-computing. New applications of these tools this will lead deeper insight into the role of networks in health as well as in clinical disorders.